Ca2+ signaling and HCO3- secretion by exocrine glands

My lab moved to the NIH July 17, 2010 and the funds were used to setup the lab. Major equipment purchased are patch-clamop setups-2, imaging setups-2, confocal microscop-1, TIRF microscop-1. So far we received only a fraction of our other orders and when we will manage to setup the lab, actual work will start. While waiting for orders to arrive, in collaboration with Dr. Ambudkar we completed a study reporting the unique expression and function of Orai1, TRPC channels and STIM1 in secretory cells. We discovered that acinar cells express to type of Ca2+ influx channels, STIM1-Orai1-TRPC1 complex and a separate STIM1-TRPC1 complex in separate plasma membrane domains. The channels appear to have separate but complimentary function in mediating cellular activity. A manuscript summarizing these studies was submitted to Traffic. We complete another study in which we discovered that TRPC channels can function in two modes, STIM1-dependent and STIM1-independent modes when stimulated by G proteins-coupled receptors. The results show that at physiological low agonist stimulation STIM1 gates TRPC channels by electrostatic interaction that is mediated by two conserved negative charges in the C terminus of TRPC channels and two positive charges in STIM1 polybasic, C terminus domain. However, at intense stimulation that mimic the pathological state of Ca2+ signaling this control is lost and the channels are activated in a STIM1-independent mode to constitutively activate Ca2+ influx. A manuscript summarizing these studies was submitted to The Journal of Biological Chemistry.